Alcohol consumption and related comorbid conditions: health state utilities for economic evaluation

PROJECT SUMMARY Effective prevention and treatment of alcohol use disorder (AUD) in the US could save more than 80,000 lives each year. Although abstinence has traditionally been the goal of AUD interventions, reductions in drinking levels have been shown to decrease the harms of AUD, providing an additional “goal post” for prevention and treatment. At the same time, patient-centered care and patient-reported outcomes are having a greater impact on health care decision-making than ever before. Thus, there is an urgent need for rigorous alcohol health services research to inform practice and policy. Moreover, it is critical that this research parallel medically-focused health services research to solidify a “level playing field” in comparative assessments for resource allocation decisions. Increasingly these resource allocation decisions are informed by cost-effectiveness analyses that use health utility as an outcome. Health utility captures individuals’ preferences for living in a given health state and is the foundation of quality adjusted life years (QALYs), the preferred outcome measure for cost-effectiveness analysis. Health utilities and QALYs are rarely used by alcohol health services researchers, however. The lack of health utilities for alcohol health states is a critical shortcoming in alcohol health services research that disadvantages alcohol services in resource allocation decisions. To promote the use of health utilities in alcohol health services research, we will conduct secondary data analyses of the National Epidemiologic Survey on Alcohol and Related Conditions-III (NESARC-III) to address the following specific aims: Aim 1: Estimate health state utilities for AUD health states stratified by alcohol consumption levels. 1.1 Estimate mean utility and variance for AUD health states based on DSM-5 severity and WHO risk levels. 1.2 Test utility differences between adjacent health states to inform the impact of reductions in AUD severity and/or consumption levels. Aim 2: Empirically and predictively derive joint health state utilities for AUD with comorbid conditions. 2.1 Estimate mean utility and variance for past year AUD with select comorbid conditions. 2.2 Test the performance of predictive algorithms for estimating joint health state utilities in AUD. As an AREA project, we will involve graduate and undergraduate students in all aspects of the study as integral members of the research team, providing intensive exposure to and training in research. We will disseminate our results to the clinical, practice, policy, and research communities to advance the use of health utility in alcohol health services research. Our findings will result in broader use of health utilities and QALYs for policy and clinical decision making in alcohol health services, and thereby lead to improved patient and population health. 1

Public health relevance
PROJECT NARRATIVE Our study will provide health utility estimates for use in alcohol health services research. It will support the use of health utilities and quality-adjusted life years in alcohol cost-effectiveness analyses, allowing for the consideration of alcohol disorders within a broader medical decision-making framework for resource allocation. 1